Identifying the presence of a code-switch: Evaluating the role of acoustic cues.

Project Summary
Many infants growing up in bilingual homes are regularly exposed to code-switching from their
caregivers and other members of their community. Even parents who aim to use the “one -parent-one-
language” method of bilingual language exposure tend to switch languages occasionally, producing
sentences such as “Do you see the gato?”. In order to develop representations of each of their
languages, which we know they do, infants must figure out not only that there are two languages in their
environment, but at what point in a given sentence one language ends and the other one begins. Making
this even harder, speakers often “blur” the distinction between languages by producing sounds in one
language that are colored by the other (known as phonetic convergence). We kn ow that this
convergence may help adult bilingual speakers to anticipate an upcoming code -switch. However, it is
not clear whether it is present in speech to infant or if listeners who do not know the languages are
sensitive to this cue. Aim 1 will test the extent to which Spanish-English bilingual parents produce cross-
linguistic phonetic convergence when speaking to their infants and to a fellow adult. I will ask them to
record narrations of wordless picture books in English, Spanish, and while switching between the two
languages (Exp. 1) and will measure how acoustic-phonetic properties of their speech are modulated
by the speech register and the presence and proximity of code-switching. Aim 2 focuses on the ability
of listeners at several levels of language experience to detect code-switches when listening to unfamiliar
languages. English monolingual (Exp. 2a) and Spanish-English bilingual (Exp. 2b) adults, and
monolingual 5-to 14-month-old infants (Exp. 3) will listen to passages that switch between Mandarin
and French and will identify the language they are hearing. I will test whether the presence of
anticipatory phonetic convergence in voice-onset time and tone influences the speed at which listeners
detect a language switch between these two rhythmically dissimilar languages. By assessing how these
anticipatory phonetic cues influence the detection of code-switching in unfamiliar languages, we will be
able to determine whether their importance to code-switching comprehension for fluent bilinguals is due
to language-specific knowledge or is a result of general speech perceptual mechanisms. This project
will also help us to better understand how infants exposed to code-switching are able to acquire two
languages simultaneously. Having more evidence of the process infants undergo in order to solve this
acquisition problem may help to provide more credibility to the suggestions we give to parents who wish
to raise their children bilingually, as current advice reassures parents that their children can easily
acquire multiple languages but does not detail how they can do that under different conditions.

Public health relevance
Project Narrative Young children being raised with multiple languages are often exposed to language switching, and in order to learn both of their languages from this switching input they must be able to distinguish between and categorize their two languages while listening. Though we know that infants succeed at this process, our understanding of the mechanisms supporting this success is still very limited. The current project examines both the speech bilingual parents use when talking to an infant and listeners’ ability to correctly identify which language they are hearing, and may provide us with more detailed evidence to support the current recommendation that parents should expose their children to the language practices of their family and community.